DLL3-targeted IL18-secreting CAR T cells in Small Cell Lung Cancer

Project Summary
Small cell lung cancer (SCLC) represents ~15% of all lung cancers and has an exceptionally poor prognosis,
(median overall survival 8-9 months and 3-year overall survival of 9-12%). Responses to frontline platinum-
based chemotherapies and programmed cell death protein 1 (PD-1) blockade are generally short-lived (median
progression-free survival [PFS] 5 months), and later-line treatments have limited efficacy (median PFS 2.6
months) and considerable toxicity. There is a critical need for novel therapeutic approaches in SCLC. The
inhibitory Notch ligand Delta-like protein 3 (DLL3) is a promising target for immune-based SCLC therapies.
DLL3 plays a critical role in SCLC tumorigenesis, is highly expressed on the surface of at least 85% of SCLCs,
and is absent from normal tissue. DLL3 targeting T cell engagers have response rates of 20-40% in the
relapsed, refractory setting with a tolerable side effect profile, but many responses are not durable.
Extrapolating from other tumor types, chimeric antigen receptor (CAR) T cells have almost double the
response rates and increased durability of responses relative to T cell engagers. CAR T cells can also be
engineered to secrete cytokines to activate endogenous anti-tumor immunity and potentially overcome antigen
heterogeneity and escape. Hence, DLL3-directed CAR T cells are poised to have increased anti-tumor activity
and durable responses compared to T cell engagers. Based on this and our preliminary studies, we
hypothesize that DLL3-directed SAVVY-IL18 CAR T cells will be safe and effective against chemotherapy and
PD-1 blockade resistant SCLC. We will test this hypothesis in the following specific aims: 1. Determine the
safety and preliminary efficacy of DLL3-targeted IL18-secreting CAR T cells in a phase 1 trial of relapsed,
refractory extensive stage SCLC. 2. Interrogate intratumoral and peripheral immune cell dynamics and
capacity of DLL3-targeted IL18-secreting CAR T cells to enhance the expansion of endogenous CAR-negative
tumor-targeted T cells. We will conduct a phase I dose escalation trial. Cohorts of 2 will be infused with
escalating doses of DLL3-SAVVY-IL-18 CAR T cells to establish the maximum tolerated dose (MTD) of CAR T
cells. Dose escalation/de- escalation decisions will be based on the modified continual reassessment method
(MCRM). To complement the clinical trial, correlative studies will be carried out to deeply characterize the
immune landscape and its evolution during treatment using next-generation sequencing, whole exome
sequencing, single-cell 5’ RNA sequencing and T cell receptor CITE sequencing, immunohistochemistry of
tumor tissue of pre- and on-treatment biopsies, and T cell receptor sequencing of peripheral blood
mononuclear cells. Promising results will lay the foundation for a larger phase 2 trial, advancing this promising
approach. The innovative T cell product proposed in this study has the potential to dramatically improve
outcomes for patients with SCLC and will also yield important insights into disease biology.

Public health relevance
Project Narrative Small cell lung cancer (SCLC) is a difficult-to-treat malignancy that is universally lethal in the advanced stage. Treatment options are limited and demonstrate modest efficacy and considerable toxicity. The innovative T cell therapy explored in this proposal is likely to have fewer side effects than current interventions, does not require preparative chemotherapy, and may provide greater relief, with the possibility of long-term remission - this approach may reduce mortality and improve quality-of-life for patients with SCLC and in the future, other DLL3-expressing cancers.